Hyperpolarized 13C MRI of Cardiac Metabolic Remodeling in Heart Disease

Project Summary
Abnormalities in cardiac energy metabolism and mitochondrial dysfunction have been implicated in numerous
heart diseases such as hypertrophic cardiomyopathy (HCM), diabetic cardiomyopathy, ischemic
cardiomyopathy, hypertensive heart disease, HFpEF, systolic and diastolic heart failure. The healthy heart has
metabolic flexibility, for example increasing fatty acid oxidation during fasting or increasing glucose oxidation
during exercise. In heart disease, there are changes in substrate selection and decreased metabolic flexibility
which precede contractile dysfunction.
We propose to develop and translate hyperpolarized (HP) 13C-pyruvate MRI for evaluating metabolic
remodeling in heart disease. It can quantify metabolic fluxes from pyruvate to acetyl-CoA via pyruvate
dehydrogenase (glucose oxidation), and pyruvate to lactate conversion via lactate dehydrogenase for measuring
glycolysis/glucose oxidation coupling. No other non-invasive imaging can achieve this. Scanning is rapid, 1-2
minutes, which allows for multiple scans to measure metabolic flexibility under glucose and exercise challenges.
In evaluating this technique, we will study HCM patients, the most common inherited cardiomyopathy with a
worldwide prevalence of ~1:250 and the leading cause of sudden cardiac death in athletes and otherwise
healthy, young individuals. HCM is a metabolic disease, and our pilot studies have demonstrated HP 13C-
pyruvate MRI visualizing metabolic remodeling in HCM patients. We propose the following specific aims:
1) Develop HP [1-13C]pyruvate MRI to assess metabolic flexibility and glycolysis-glucose oxidation coupling:
scans after fasting and glucose load, rest and after handgrip exercise, and metabolism quantification methods
2) Translate into HCM patients, investigating correlations between metabolism and exercise capacity, substrate
availability, and contractile reserve, as well as differences in HCM disease stage, genotype, and phenotype.
3) Examine the effect of 2 HCM treatments, namely recently FDA approved cardiac myosin ATPase inhibitors
and exercise-training, on cardiac metabolic flexibility and glycolysis-glucose oxidation coupling, with HP 13C-
pyruvate MRI scans at baseline and after 6-8 months of treatment.
4) Develop next-generation HP MRI methods, including refocused imaging methods to improve resolution/SNR,
and [2-13C]pyruvate methods for interrogation of TCA cycle flux that is more directly coupled to fatty acid
oxidation and reflects mitochondrial function. These will utilize fast acquisitions to freeze heart motion.
This translational imaging development will enable unprecedented individualized, regional and global profiles of
cardiac metabolism, allowing for preclinical detection, management, and prognosis of heart disease. There is an
immediate need for this in HCM, but the techniques developed have broad applicability and impact for examining
metabolic defects, abnormalities, and remodeling in heart diseases, with direct translation into the clinic.

Public health relevance
Project Narrative Heart failure is a global pandemic and is increasing in prevalence worldwide, and abnormalities in cardiac metabolism have been implicated in the genesis of cardiomyopathies and heart failure – no surprise given the massive energy demands of the heart. This project proposes development of a metabolic imaging method, hyperpolarized carbon-13 MRI, to measure key processes in glucose metabolism that are altered in heart disease, which cannot be measured by any existing technique. We will develop techniques for hyperpolarized carbon-13 MRI scanning and image analysis, and apply these to hypertrophic cardiomyopathy (HCM) patient studies where we expect to observe regional and global changes in glucose metabolism that correlate with clinical phenotype and are modulated by cutting-edge treatment strategies.